SELECTIVE EXPRESSION OF AGM1 DURING LYMPHOPOIESIS

Evidence has been accumulating that cell membrane glycosphingolipids may serve as receptors for several biologically active agents including glycoprotein hormones, lymphokines and interferon and may play a role in cell activation. Using purified antibodies to aGM1, it has been demonstrated that this glycosphingolipid is expressed predominantly by cells in the T-lymphocyte lineage. The expression of aGM1 seems to be associated with functionally responsive status within the lineage. The aGM1 is expressed throughout the lineage and is exposed, masked, and re-exposed at certain stages of maturation and activation. We have demonstrated that a proportion of the multipotential hematopoietic stem cells (CFU-S) also expresses aGM1. The aGM1-positive CFU-S display a reduced self-renewal potential and are depleted in athymic mice. In the context of current theories of hematopoiesis, decreased self-renewal is associated with increased cell cycle activity and propensity to differentiate into committed progenitors. Thus the aGM1-positive CFU-S may represent mobilized stem cells, a subset of thymic dependent stem cells, or both. To attempt to resolve these questions, we propose to determine if aGM1 phenotype is associated with cell cycle activity of CFU-S and to determine if there is a difference in T cell dependency for self-renewal and differentiation of stem cell subpopulations defined by aGM1 phenotype. These studies will elucidate the bases for hematopoietic commitment and regulation at the stem cell level and thus provide a basis for studies on the mechanism of hematopoietic dysfunction in congenital, age-related and transplantation-related syndromes.